Discovery and interrogation of genetic regulatory variation impacting Atrial Fibrillation risk

Abstract
The overall goal of this multi-principal investigator proposal is to facilitate the transition from implication
of genetic variants identified in extensive genome wide association studies (GWAS) of Atrial Fibrillation (AF) to
the molecular mechanisms underlying AF risk. We hypothesize that a novel genomic and analytic pipeline
interrogating regulatory function of genetic variation will identify candidate causative variants and their target
genes, enabling the transition from simple associations to causative mechanisms for the arrhythmia. In
preliminary studies, we have applied novel single cell approaches to generate cell-type-resolved high-resolution
chromosome accessibility maps and taken advantage of coordinated genomic signals to link AF risk variants to
candidate causative AF genes. The results describe a highly interconnected gene regulatory network for cardiac
atrial gene expression. In our first aim we propose to generate multi-modal single-cell genomics data to provide
higher-resolution annotation of variant effects. We will improve our computational procedure to better leverage
these datasets for AF variant and gene discovery. In our second aim, we will interrogate the interconnected
gene regulatory network in molecular enhancer assays and genomic chromatin conformation capture
experiments, to directly examine the impact of nominated genetic variants and their physical association with
candidate target genes. In our third aim, we will examine the functionality of high confidence variant SNPs in
depth, including their impact on gene regulation in cis, their impact on human cardiomyocyte electrophysiology,
and their impact on cardiomyocyte gene expression and chromatin status in trans. We have established a
tractable strategy that will help enable the transition from AF risk variants to molecular mechanisms. We
anticipate that our approach will help translate the promise of AF genetics into meaningful biological insights for
AF and establish a paradigm for the molecular understanding of genetic association studies in any system.

Public health relevance
Project Narrative Genome Wide Association Studies (GWAS) have identified over 100 loci contributing to the risk of Atrial Fibrillation, however, the molecular mechanisms underlying their genetic implication remains unknown. We propose to apply a novel single cell genomic and analytic approach to identify causative risk variants and their target genes, analyze the molecular basis of the risk loci, and interrogate several risk SNPs in detailed molecular, genomic, and electrophysiological studies in human cardiomyocytes. The results will generate biological insight from genetic implication, delivering a greater understanding of the genetic basis of Atrial Fibrillation.